Antibiotic Resistance Surveillance in Retail Meat and Seafood Samples from South Dakota and North Dakota.

The objective of the FDA-NARMS cooperative agreement program (CAP) is to build a network of 30
laboratories distributed throughout the United States to determine the prevalence of antimicrobial
resistance among bacteria (Salmonella, Campylobacter, Aeromonas, Vibrio, E. coli, CPE, and
enterococci) isolated from samples of chicken, ground turkey, ground beef, ground pork, tilapia,
salmon and shrimp purchased from grocery stores. Our proposed portion of this CAP grant would
be to determine the prevalence of antibiotic resistance among these microbes isolated from retail
meat and seafood samples from South Dakota and North Dakota stores. One hundred and twenty
one retail meat and seafood samples will be purchased each quarter for five years from each of two
sites in both South Dakota and North Dakota. These retail meat and seafood samples will be
delivered to the Food Safety Microbiology (FSM) Laboratory in the Animal Disease Research and
Diagnostic Laboratory at South Dakota State University. All samples will be tested for the presence
of Salmonella, Campylobacter, Aeromonas, Vibrio, E. coli, CPE and Enterococci using established
food safety analysis protocols. The microbes isolated from these food samples will be shipped to
FDA-CVM for analysis of antibiotic resistance profiles. Isolates of Campylobacter, Salmonella, and E.
coli will be sequenced onsite and uploaded to the FDA database utilizing existing GenomeTrakr
pipelines. These results will be compiled and distributed back to the FSM lab for dissemination to
the Cooperative Extension Services, Consumers, and Producers.

Public health relevance
The relevance of this research to public health is that it will help to provide an assessment of the current state of antimicrobial resistance among bacteria that are commonly found in meat and seafood consumed by humans. The results of this study will be essential in determining parameters for antimicrobial use in the treatment of animals, and for developing “One-Health” interventions to reduce the spread of antimicrobial resistance between animals and humans.